St. Louis Summer Research Immersion Program

Abstract
Increasing diversity and inclusiveness within the Pediatric Neurosciences workforce will help close the gap in
health disparities and accelerate research efforts that will lead to new treatments for pediatric brain disorders.
Minority populations are affected by cognitive and neurological conditions at a rate higher than other groups, yet
they are involved in neuroscience research at a much lower rate. The NIH/NINDS has demonstrated leadership
in addressing this critical disparity by creating an NINDS Office of Programs to Enhance Neuroscience Workforce
Diversity (OPEN) and developing specific individual and institutional funding opportunities to promote inclusion
across the NINDS scientific portfolio. The current proposal will create the St. Louis Summer Research Immersion
Program in Pediatric Neuroscience (SSRIP) to provide an innovative research training experience to high school
students who might not otherwise have access to such opportunities. This R25 research education program is
both innovative and responsive to the priorities of the NINDS. It directly addresses the stated priorities of the
NINDS to eliminate disparities in the Pediatric Neurosciences workforce, enhance creativity and innovation
through diverse representation, broaden the scope of biomedical inquiry, and ensure fairness in our diverse
nation. Further, the SSRIP models the NIH Scientific Diversity Toolkit by developing all four key focus areas: 1)
a diverse candidate pool; 2) unbiased talent searches; 3) outreach and networking; and 4) mentoring
relationships. Washington University's educational environment presents an ideal context and substantial
existing infrastructure to develop this unique training program. Thus, in addressing PAR-21-168, SSRIP will
advance the collective mission of the NINDS, WUSM, and the St. Louis community of enhancing the diversity
and inclusiveness of the Pediatric Neurosciences research workforce both locally and more broadly.

Public health relevance
Narrative The future of child and adolescent development and behavioral medicine lies in enhancing the diversity and inclusiveness of the research and clinical workforce. The proposed St. Louis Summer Research Immersion Program in Pediatric Neuroscience (SSRIP) will provide a unique and innovative research training experience to high school students who might not otherwise have access to such opportunities. Thus, this proposed R25 program will `grow the pipeline' for early stage learners for research careers in Pediatric Neuroscience, which has been designated by the NIH/NINDS as a priority area for a diverse workforce.